Novel hematopoietic humanized mouse model to study CAR-T therapy-associated cytokine release syndrome

Project Summary
Adoptive transfer of T cells genetically engineered to express CD19-specific chimeric antigen receptors (CARs)
have achieved tremendous clinical success in treating patients with refractory and relapsed B-cell leukemia.
Since the approval of CD19 CAR-T cells in 2017 by the US Food and Drug Administration (FDA), research in
the field has grown exponentially, ranging from therapies for melanoma and solid tumors, induction of
transplantation tolerance to treatment of autoimmune diseases. Despite these successes, the treatment also
has severe toxicities due to the excessive immune responses. Cytokine release syndrome (CRS), manifesting
as serum cytokine over-production, fever, hypotension, and multiple organ dysfunction/failure, is one of the
major side effects that can cause permanent damage to patients if left without proper clinical intervention.
While clinical protocols have been developed to mitigate the pathophysiology of CRS in clinic, the underlying
mechanisms responsible for the excessive cytokine secretion remains not fully understood. One of the major
hurdles is the lack of preclinical models that can fully recapitulate the CAR-T cell-mediated immune
interactions.
Hematopoietic humanized (hu) mouse models are a powerful platform to bridge the gap between preclinical
studies and clinical CRS, and have been instrumental in developing novel therapies to mitigate CRS-
medicated toxicities. However, recreating the complex human immune system in these mice is challenging, as
they don’t have a human thymus, the primary lymphoid organ responsible for the generation and selection of T
cells. Although the endogenous mouse thymus can provide limited support for human T cell development,
human T cells generated in mouse thymus cannot properly engage with other human immune cells to regulate
effective immune responses. We have recently developed a tissue-engineering method to generate human
thymus from inducible pluripotent stem cells (iPSCs). iPSC-derived human thymus can support the de novo
generation of a functional human T cell compartment in hu mice that can mediate both cellular and humoral
immune responses. Based on these findings, we hypothesize that hu mice engrafted with iPSC-thymus can
recapitulate the complex interactions between the human immune system and cancer cells under CAR-T
therapy, and serve as a powerful model to study CRS pathophysiologies for the discovery of novel therapies.
In this exploratory project, we are going to establish and characterize a CD19 CAR-T/B-lymphoblastic cancer
model with the iPSC-thymus engrafted hu mice to recapitulate CRS and its associated toxicities. If successful,
the project will have broad impacts in the field of immunotherapy.

Public health relevance
Project Narrative Chimeric antigen receptor (CAR)-based T-cell transfer therapy has achieved tremendous clinical success in treating refractory and relapse B cell lymphoblastic cancers. However, the treatment can also lead to over production of inflammatory molecules in some patients, which could be life threatening without clinical intervention. In this exploratory R21 project, we will develop a novel animal model to further understand these CAR-T treatment-associated toxicities. The work will unravel novel factors and cell types responsible for the progression of these side effects, and help to develop novel therapies to mitigate and/or prevent them.